MTSS1 in myocardial disease

PROJECT SUMMARY
Myocardial disorders lead to heart failure (HF) and impose an enormous public health burden. Changes in
cardiac structure and function that accompany myocardial disease and HF are heritable traits. MTSS1
(metastasis suppressor 1) is an I-BAR protein that regulates cytoskeleton dynamics, cell motility, and adhesion.
Our group identified genetic variants in a cardiac-specific enhancer upstream of MTSS1 that reduce human left
ventricular (LV) MTSS1 expression, resulting in reduced LV size and reduced risk of dilated cardiomyopathy
(DCM). These findings established MTSS1 as a genetic modifier of cardiac structure and function, and motivated
the hypothesis MTSS1 reduction would protect against myocardial disease.
In the first cycle of this award, we demonstrated that MTSS1 reduction partially rescues cardiac function in female
but not male mice in vivo in a transgenic model of human DCM. To study effects in humans, we fine-mapped the
MTSS1 locus with cardiac magnetic resonance imaging (CMR) traits in UK Biobank. Concordant with our mouse
studies, associations between MTSS1 and CMR traits were evident almost exclusively in women, and MTSS1
alleles improved cardiac function in women—but not in men—who carried pathogenetic DCM variants. Our
findings at the MTSS1 locus suggest a genetic basis for sex dimorphism in cardiac remodeling.
Sex differences in cardiac traits and HF have been appreciated for decades. Remarkably, sex-specific effects
have been largely ignored in cardiovascular genomics. Few genome wide association studies (GWAS) for
cardiac traits and disease have been conducted separately in men and women; interactions between cardiac
loci and sex or sex hormones are unexplored, and sex chromosomes themselves have been excluded from most
GWAS. Our preliminary analyses indicate that MTSS1 is one of least 20 cardiac modifier loci that show sex
dimorphism and may thus contribute to sex differences in myocardial disease.
Our renewal application will elucidate sex-specific effects of modifier loci on cardiac structure, function,
and failure using MTSS1 as an exemplar. Our approach will build on resources developed during the first
award cycle, including consolidated access to global HF genomic data and experimental HF models already
established in our laboratories. Aim I will determine genetic mechanisms through which MTSS1 and other
modifier loci show sex-specific effects on cardiac traits. Aim II will test if sex-specific effects of MTSS1 and other
modifiers will translate into sex differences in myocardial disease and clinical HF. Aim III will use experiments in
HF models to prove, or refute, sex-specific mechanisms. If successful, our proposal will expand a paradigm
revealed through MTSS1 into a broad understanding of genetic contributors to sex differences in myocardial
disease. Doing so will advance cardiac biology, genetics, and precision medicine by identifying sex-specific risk
factors and treatment targets for human heart failure.

Public health relevance
PROJECT NARRATIVE Women who are born with naturally occurring DNA variants that decrease the activity of the MTSS1 gene appear to be protected against heart failure, but men do not appear to share this benefit. This project will research populations and use animal models to understand why MTSS1, and other genes we have identified, affect the heart only in one sex. Our findings may explain well known sex differences in heart failure and will suggest risk factors and treatment approaches tailored to women or to men.